Characterizing the interaction between neural attention and somato-motor systems in non-demented patients with Parkinson's disease

ABSTRACT/PROJECT SUMMARY
Parkinson’s disease (PD) is a progressive neurodegenerative disorder that presents a looming economic and
societal challenge in the United States and worldwide. Despite being primarily a disorder of the motor system
(i.e., the brain systems controlling movement), patients with PD are also known to exhibit profound deficits in
attention, which is our ability to direct brain resources towards important aspects of the environment. Importantly,
these issues are not isolated from one another, as attentional issues are robustly linked to risk of falls in patients
with PD, which are the most common reason for hospitalization and major injury in this population. Indeed,
attention-based therapies have been developed for patients with PD and have been moderately successful, but
a great deal of variability exists in patient outcomes. This variability is largely due to the lack of specific
neurophysiological and cognitive targets of these therapies, so a better understanding of the brain systems being
affected is essential to improving patient outcomes. The current project aims to identify and quantify the brain-
basis of attentional impairments in patients with PD, as well as the neurophysiology underlying the interactions
between these deficient attentional sub-systems and somato-motor systems. The primary goal of this research
will be to provide novel targets for enhanced clinical interventions, such as brain stimulation and attention-training
therapies. A secondary goal of this project is to provide a data-driven framework for the assessment of attention-
training in the brains of patients with PD, and the impact of this training on the brain circuits that control movement
(i.e., somato-motor networks). To reach these goals, a series of innovative cognitive neuroscience experiments
will be utilized, combined with advanced brain imaging techniques. These data will be collected using expansive
data repositories available in Montreal (the Quebec Parkinson Network and the Montreal Neurological Institute
Clinical Biological Imaging and Genetic Repository) and analyzed using a number of highly innovative signal
processing techniques developed by Professor Sylvain Baillet in his state-of-the-art software housed in his
laboratory at McGill University (Brainstorm; > 23,000 users worldwide).
These studies which will allow for novel investigations of the role of dynamic brain activity patterns between and
within attention and somato-motor networks in patients with PD. This will provide new targets for attention-
training and brain stimulation therapies, while also enhancing our understanding of the neurobiological
aberrations that contribute to PD. The aim of my research project is to understand (1) which attentional neural
sub-systems are being preferentially affected by PD, and (2) how these attentional sub-systems interact with
established PD-related somato-motor system aberrations. These findings will then provide key metrics for the
assessment of treatment efficacy, as well as targets for therapeutic intervention. With the prevalence of PD rising
both nationally and worldwide, concrete targets for intervention are desperately needed to minimize the impact
of this debilitating disorder, both on the personal level for those affected, and broadly on a socio-economic scale.

Public health relevance
PROJECT NARRATIVE The current project aims to identify and quantify the brain-basis of attention problems, as well as their impact on movement, in patients with PD. The primary goal of this research will be to provide novel targets for enhanced clinical interventions, such as brain stimulation and attention-training therapies. A secondary goal of this project is to provide a data-driven framework for the assessment of attention-training in the brains of patients with PD, and the impact of this training on the brain circuits that control movement (i.e., somato-motor networks).